Molecular Oncology Training Program

PROJECT SUMMARY
This is a proposal to re-fund a recently established post-doctoral training program at Columbia University focused
on training physicians in research techniques that will form the basis of careers in translational investigation of
cancer biology, diagnosis and treatment. We will identify and recruit individuals with outstanding research
potential who have completed clinical training in medical oncology and prepare them for productive careers as
translational investigators in oncology. We will utilize a comprehensive two-year program comprised of didactics,
workshops, small group sessions, coursework, including a possible master's degree, and individualized training
within the research programs of Columbia University faculty to develop the careers of the participants. Funds
are requested in a graded fashion to support up to 6 trainees annually.
The Molecular Oncology Training Program faculty is comprised of 46 independent investigators who will provide
direct supervision of the trainees. The faculty members are uniformly funded by the NCI, other branches of the
NIH and other cancer-focused research organizations and have established themselves as thought-leaders in a
broad range of cancer-related disciplines. Faculty members are divided into the main thematic areas of the
training program: I) Precision Oncology and Systems Biology, II) Cancer Genomics and Epigenomics and III)
Tumor Biology and Microenvironment. Participating faculty have been identified on the basis of their research
productivity and quality, demonstrated collaboration with other investigators, often across research disciplines,
and a history of supporting and developing research careers that transition beyond the post-doctoral level. The
trainees will be chosen competitively from a highly select group of committed physician researchers on the basis
of past accomplishments and their potential to develop careers as productive, independent translational
investigators.
The Molecular Oncology Training Program will be supported by the diverse research resources at Columbia
University and the ongoing expansion and commitment to oncology that has included both laboratory and
clinically focused research. The expansion was heralded by the opening of the Irving Cancer Research Center
a 300,000 square-foot building within the Columbia University Irving Medical Center that is entirely dedicated to
cancer research and the ongoing recruitment of leading clinical-translational research faculty to the Division of
Hematology and Medical Oncology. These changes have significantly broadened the diversity of research at
Columbia University with a concomitant increase in quality that has established Columbia in the top tier of
oncology programs and has attracted a pool of consummately trained physicians committed to careers in
translational cancer biology.

Public health relevance
PROJECT NARRATIVE Cancer diagnosis and treatment has become much more complex over the past several years. We propose a continuing a training program using the considerable resources of Columbia University Irving Medical Center to provide cancer physicians of outstanding promise the tools and skills that will be needed to make key discoveries and to develop productive research careers in academic medicine.